Identifying Novel Diagnostics and Mechanisms for Cardiac Allograft Vasculopathy

PROJECT SUMMARY/ABSTRACT
The proposed K23 Career Development Award will enable Dr. Kevin Clerkin to establish an independent
research career with expertise in the diagnosis and mechanism of cardiac allograft vasculopathy (CAV). Dr.
Clerkin is a clinical advanced heart failure & transplant cardiologist, whose long-term goal is to optimize outcomes
of heart transplant recipients with respect to CAV. However, further training is required to achieve that goal. As
such, he has assembled a multidisciplinary team of mentors with individual expertise in: (1) transplant cardiology
(2) transplant immunology (3) clinical trial design and conduct (4) multimodality cardiac imaging and (5) research
dissemination. The career development plan includes formal coursework and mentored meetings in transplant
immunology and clinical trial design. Additionally, it involves activities and mentored experiences in career
development, research dissemination, and grantsmanship. Heart transplantation is the gold standard treatment
for end-stage heart failure, afflicting ~250,000 Americans annually. Given that CAV is the cause of death for up
to 1/3rd of transplant patients, it is necessary to improve our understanding and ability to diagnose CAV. The
primary objective of this K23 research training is to improve diagnostics for CAV and identify mechanisms
instigating early CAV in order to lay the groundwork for future studies to test therapies targeting that pathway.
This proposal consists of two interrelated studies to achieve this objective through clinical and translational
research. In the first, we hypothesize that physiology based screening (measuring coronary blood flow or
coronary flow reserve [CFR]) will improve the diagnosis of CAV over traditional angiography. We also
hypothesize that CFR measured on a non-invasive cardiac PET scan will correlate with CFR measured using a
pressure wire during coronary angiography, thereby allowing for a new primarily non-invasive screening
approach. In the second translational study we will leverage the careful CAV phenotyping of Study 1 to explore
clonal hematopoiesis of indeterminate potential (CHIP) as a potential mechanism for early CAV. CHIP in adults
has been associated with an increased risk of atherosclerosis, mediated by increased inflammatory macrophage
chemokines and cytokines. While presently nothing is known of its impact on CAV, based on our previous work
identifying populations of macrophages surrounding coronary arteries of patients retransplanted for CAV, we
hypothesize that patients with CHIP will have an increased risk of CAV. Targeted gene sequencing will be
performed on peripheral blood samples from patients in our biobank in an effort to detect the presence of CHIP
and assess its association with early CAV. This K23 proposal will position Dr. Clerkin to accomplish his goals of
1) improving diagnosis of CAV, 2) identifying a novel target for optimizing CAV related patient outcomes post-
heart transplant, and 3) facilitating his development into an independent investigator in the field of transplant
cardiology.

Public health relevance
PROJECT NARRATIVE Cardiac allograft vasculopathy is a pan-arterial disease that impacts 50% of patients within ten years of heart transplantation and is the cause of death for up to 1/3rd of patients. Currently our understanding of the mechanism of CAV and the standard modalities to diagnose CAV are insufficient. Achieving our aims will set the stage for a change in the diagnostic paradigm for cardiac allograft vasculopathy and advance our understanding of the pathophysiologic mechanism for the disease that impacts the majority of heart transplant recipients.